HARC: HIV accessory and regulatory complexes

The mission of the Administrative Core is to support and promote the scientific and collaborative goals of the
HARC Center. The Core will provide leadership that ensures strong oversight and representation of all
stakeholders in decisions, facilitate the integration of research projects, and connect the HARC Center to the
broader NIAID Centers for HIV Structural Biology. Day-to-day activities will be coordinated by a team co-lead
by the HARC Center Director (Dr. Nevan Krogan), who has extensive experience leading and managing large
research centers, and the Administrative Core co-Investigator (Dr. Lorena Zuliani-Alvarez). They will be
supported by the UCSF Quantitative Biosciences Institute (QBI) administrative team. Evaluation of progress
toward the Center's goals as well as budgeting and long-term planning of center activities will be performed by
the HARC Center Executive Committee (EC), consisting of the Director, Project leads (Drs. Gross, Marson,
and Frankel) and the Administrative Core (Zuliani-Alvarez). As a first task of the Executive Committee, a
Scientific Advisory Board (SAB) will be formed to review the Center's progress and future plans. The
Administrative Core will organize and manage a number of regularly scheduled meetings for the EC, the
entire HARC Center, and the wider HIV research community to facilitate communication amongst members
and provide ample opportunities to discuss overall research directions and specific experimental concerns. In
collaboration with the Developmental Core, the Administrative Core will maintain the HARC Center website
(harc.ucsf.edu) and shared file servers. To provide formal site review and involvement with NIAID staff, the
Core will organize an annual SAB Meeting, in which the Pls and key personnel will meet with the SAB and
NIAID program staff to review the Center's activities. The HARC Center's outreach activities will encompass
workshops, podcasts, and internships for students and will be supported by the QBI Media & Events team.

Public health relevance
THE HARC CENTER: HIV ACCESSORY AND REGULATORY COMPLEXES OVERALL NARRATIVE The HARC Center’s powerful “Systems-to-Structure” platform will uncover the mechanisms that allow HIV to inhibit host restriction factors, reveal the factors regulating HIV transcription and latency, and investigate virus- host evolution to identify new treatment strategies by targeting key cellular processes.